Novel antimicrobials targeting MDR pathogens from animal microbial symbionts

Project Summary
The discovery of new antimicrobials has failed to keep pace with the emergence of antimicrobial-resistant
infections, threatening public health. The overarching goal of the Wisconsin Antimicrobial Drug Discovery and
Development Center is to develop therapeutic countermeasures to tackle the antimicrobial resistance crisis.
Based upon our preliminary investigations using interdisciplinary, cutting-edge approaches, we hypothesize that
natural products from animal-microbe symbioses represent a new paradigm in antimicrobial drug discovery. The
Center proposes innovative conceptual and technical advances to overcome the critical bottlenecks of traditional
antimicrobial discovery to deliver therapeutic countermeasures for the drug-resistance epidemic.
Relevance
There is an ever-present and growing need to find novel, effective therapies for emerging resistant pathogens
that are becoming an increasing threat to the public health. The goals of the Center are to discover new
antimicrobial drugs. Our collaborative effort focuses on high-value natural products produced by under-
explored sources of biological and chemical diversity.

Public health relevance
Narrative: Fungal and bacterial pathogens for which there are no effective therapies are rapidly emerging. The proposed investigations will develop a new platform for discovery of the next generation of antimicrobial drugs. This new platform takes advantage of the evolutionary selection of highly relevant natural products from symbiotic relationships between animals and antibiotic producing bacterial.